University of Miami Developmental HIV/AIDS Mental Health Research Center (D-ARC)

Project Summary Developmental Core B
The overarching objective of the Developmental (Dev) Core for the University of Miami (UM) D-ARC is to build
and sustain the pipeline of investigators pursuing mental health (MH) HIV research that can mitigate the
disparities experienced by racial/ethnic, sexual, and gender minority populations in South Florida, a US
HIV/AIDS epicenter. Consistent with the theme of the D-ARC, our efforts will be focused on promoting
community-engaged research to reduce MH and minority health disparities across the HIV prevention and care
continua. The work of the Dev Core will be crucial to capitalizing on our success over the past three years in
recruiting six new faculty members at the University of Miami with expertise in MH HIV research.
The pilot awards program will support the efforts of UM D-ARC investigators to pursue community-
engaged, MH HIV research focused on mitigating health disparities in South Florida. The Core will guide
investigators, especially Early Stage Investigators (ESIs), in pre-submission consultations with the Methods
Core on research design and analysis and the MH Disparities Core on community-engaged approaches. The
Dev Core will coordinate competitive review of each pilot award that includes a community reviewer in addition
to two scientific reviewers. We will systematically track the progress of pilot awardees in pursuing extramural
funding and support those who are not selected to receive pilot award funds to revise their proposals.
A comprehensive mentoring program will anchor our efforts to support ESI career development in MH
HIV research. The Dev Core’s Mentoring Advisory Committee will oversee comprehensive mentoring of ESIs,
guiding them in assembling a multi-disciplinary mentoring team and developing individualized development
plans (IDPs). The Dev Core also will contribute to and facilitate access of ESIs to ongoing career development
and grant writing workshops conducted by the Miami Center for AIDS Research (CFAR), the UM Clinical and
Translational Sciences Institute (CTSI), and Center for Latino Health Research Opportunities (CLaRO).
The Dev Core will implement activities to maximize success of all D-ARC scientists in conducting
rigorous research. Pre-submission peer reviews of works in progress (e.g., grants, manuscripts) will
accelerate the pace of cutting-edge MH HIV research in our D-ARC. An annual writing retreat will create
opportunities for iterative peer reviews of scientific works in progress. Targeted Action Groups will cultivate
synergies with CFAR scientists to build interdisciplinary collaborations relevant to MH HIV research.
The interdisciplinary Dev Core leadership is crucial to the success of the overall mission and scientific
aims of the first D-ARC in the Southeastern US in supporting community-engaged MH HIV research that builds
upon the 25 year legacy of bio-behavioral MH HIV research and training at UM. Through careful coordination
with other D-ARC cores, the Dev Core will provide crucial resources to reinvigorate MH HIV research in a
region that is among the most heavily affected by the epidemic.

Public health relevance
Project Narrative for Other Components Please see Overall Component for Project Narrative. PAR-15-196 Guidelines Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components. SF424 Guidelines Overall Component: The "Project Narrative" attachment is required. Other Components: Refer to the specific FOA to determine whether the "Project Narrative" attachment is required for any Other